Diversity Supplement -- Vertebrate Photoreceptor Development and Regeneration

PROJECT SUMMARY
Inherited retinal dystrophies such as retinitis pigmentosa (RP) are a leading cause of blindness for
which there is currently no cure. One potential treatment for retinal degenerative diseases is cell-
based transplantation therapy, whereby precursor cells are transplanted into the diseased eye to
replace the lost photoreceptors. While this is an exciting possibility, several challenges to the
implementation of transplantation therapies must be overcome, including the inefficient integration of
photoreceptor precursors into the recipient retina, and the difficulty of obtaining sufficient numbers of
photoreceptor precursors for clinical application. To improve protocols for the in vitro culture of such
cells, we must have a better understanding of the transcriptional networks that promote specification
of photoreceptor precursors. One of the long-term goals of our laboratory is to contribute to these
efforts by studying photoreceptor development and regeneration in the zebrafish. The zebrafish is
especially useful for studying photoreceptor biology, because its retina contains numerous cone
subtypes in addition to rods. Furthermore, the zebrafish retina is able to regenerate neurons in
response to experimental damage. The experiments described in this proposal will define the role of
three transcription factors -- Sox, Sox11, and Her9 -- during retinal neurogenesis through the
application of gene targeting and molecular genetic approaches. Our specific aims are as follows:
Specific Aim I: Determine the role of Sox4 and Sox11 in photoreceptor differentiation. Using newly
generated loss-of-function mutants, we will 1) determine whether there is a dosage effect of Sox4/11
activity on rod photoreceptor number; 2) use state-of-the-art time-lapse imaging to determine when
and where Sox4 expression is required to achieve proper rod photoreceptor development; 3)
determine precisely how Sox4/11 regulate Hh and Bmp signaling; and 4) identify the molecular
targets of Sox4/11. Specific Aim II: Determine the cause and extent of photoreceptor defects in the
zebrafish her9 mutant. In this aim, we will 1) determine the mechanism for photoreceptor defects in
her9 mutants; 2) determine whether loss of Her9 impairs vision; 3) identify the upstream signaling
pathway(s) that regulate her9 expression in the retina; and 4) determine whether Her9-mediated
VEGF expression in the avascular zebrafish retina regulates retinal progenitor cell proliferation and
differentiation. Completion of our proposal will bridge important gaps in our understanding of the
molecular mechanisms of vertebrate photoreceptor differentiation, and reveal underlying principles
relevant to the development of approaches for the treatment of human retinal degenerative disease.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO HUMAN HEALTH The development of therapies to treat visual impairment resulting from photoreceptor degeneration will directly benefit from studies of animal models such as the zebrafish, which develops ex utero, remains optically transparent throughout development, and which displays the capacity for injury-induced neural regeneration. The goal of our proposal is to define the role of the transcription factors Sox4, Sox11, and Her9, in the development of photoreceptor cells, and to identify the pathways that regulate their expression, and what they in turn regulate. This information will facilitate efforts to understand photoreceptor developmental biology and to guide photoreceptor differentiation from stem cells in vitro and in vivo for therapeutic purposes.